New mechanisms behind skeletal muscle endurance

Stretch Activation (SA), a delayed force increase (FSA) following a rapid stretch, is known to be critical to the
function of some muscle types, such as cardiac muscle, but its purpose in other types is not known. Even less
is known about the mechanisms behind SA, limiting our ability to treat diseases involving SA loss. The few
previous investigations of mammalian skeletal muscle suggested its FSA is too low to be important for function.
However, our measurements of mouse slow-twitch muscle FSA at moderate and higher [Pi] contradict this
interpretation, suggesting SA contributes at least 1/3 of total force generation during prolonged use. This would
increase slow muscle endurance by maintaining force production when calcium-activated force production
declines and [Pi] increases, such as during long-distance running. For Specific Aim 1 we will test our
hypothesis that stretch activation is a previously unknown, alternative way to maintain force production,
and that stretch activation contributes to mammalian skeletal muscle endurance. We will test this by
measuring SA characteristics and power from skinned and live mouse soleus and extensor digitorum longus
fibers subjected to extended use conditions. SA’s mechanism in skeletal muscle is completely unknown.
However, our experiments with Drosophila and mice strongly suggest two myosin-based mechanisms for
different fiber types. Our proposed soleus mechanism involves a reversible power stroke that does not occur in
EDL myosin isoforms. This would enable soleus fibers to store and return energy from stretch in their myosins,
increasing muscle efficiency. For Specific Aim 2 we will determine the kinetic and structural mechanisms
that differentiate skeletal muscle SA characteristics. Tests of our mechanisms include optical trapping
experiments with different myosin isoforms to assess key aspects of our models and fitting cross-bridge model
equations to our mammalian SA tension transients. We will test our hypothesis that a specific myosin structural
domain is responsible for the SA response differences by measuring SA characteristics of Drosophila muscle
expressing chimeric myosins. If our kinetic mechanisms are correct, this structural experiment will determine the
region of myosin that determines if a myosin isoform’s power-stroke is reversable. For Specific Aim 3 we will
test our hypothesis that disrupted SA properties contribute to hypertrophic cardiomyopathy (HCM) and
myosin based skeletal muscle diseases. We will test if the mechanisms of two of our Drosophila HCM models
include altered SA characteristics, and create three new Drosophila models where the HCM mutations are in a
domain our preliminary results suggest is critical for endowing stretch-activated force. We will test two models of
Distal Arthrogryposis, one with a severe and the other a mild phenotype, for alterations to SA. Our combined
use of mammalian and Drosophila models is particularly powerful for uncovering new, fundamental knowledge
into SA’s roles and mechanisms, and will propel us toward our long-term goal of applying insights from SA to
restore impaired muscle function.

Public health relevance
PROJECT NARRATIVE We will determine the mechanisms and roles for stretch activation (SA) in different skeletal muscle fiber types. We hypothesize that SA contributes to the high level of endurance exhibited by slow skeletal muscles, that the mechanism behind SA in skeletal muscle involves a reversable myosin power stroke and that altered SA in heart muscle is a mechanism behind hypertrophic cardiomyopathy and myosin based skeletal muscle diseases.